Characterizing the role of affective information in early word learning using observational and experimental designs

PROJECT SUMMARY
Children learn language in the context of complex and multidimensional social interactions. Affective
information is a prominent yet, underexplored feature of children's early learning context despite its effects on
infants' attention and memory systems.1–3 Understanding how children’s affective environments shape learning
is an important public health issue, as approximately a third of mothers in the US experience depression in the
first three years of a child’s life.4 The proposed research aims to fill this knowledge gap by capturing
theoretically important dimensions of affect (such as valence and arousal5) in children’s real-world early
environments, with the ultimate translational goal of understanding the genesis of variation in language and
well-being. Central to this goal will be evaluating how children adapt their use of affective information in
families with depressed caregivers. We will quantify the affective context of learning events using multiple
methods, including experimental studies and descriptive computer vision and machine learning analyses of a
large dataset of egocentric-view videos of children’s home environment.
In Aim 1, we will ask whether the structure of affective information in caregiver input predicts the age at
which children produce different types of words (Aim 1a) and how children adapt to the affective cues of
caregivers with depression symptoms (Aim 1b). We will use automatically coded affective features from videos
across three modalities (facial, vocal, and semantic) to predict the age at which children produce different
words depending on the severity of their caregivers’ depression symptoms. In Aim 2, we build on the
correlational, naturalistic evidence from Aim 1 by taking an experimental approach, allowing us to uncover
causal links between affect and word learning. Specifically, in three novel word-learning studies, we will
disentangle which dimensions of affect (e.g., valence and arousal) are most impactful.
Together, this research will provide insight into the affective mechanisms that promote word learning in
child-caregiver interactions, with the ultimate goal of improving resilience and language development in
households with atypical affective dynamics. Through these aims, the applicant will build on her background in
affective development and gain training in computational methods and theoretical knowledge in understanding
clinical variation in affect across households. The sponsor, Dr. Michael Frank, has deep expertise in early
learning and extensive mentorship experience in developmental and computational methods. The co-sponsor,
Dr. Ian Gotlib, is an expert in the study of caregiver depression. The unique training environment at Stanford
University provides the resources necessary to successfully complete the proposed work, as well as additional
opportunities for mentorship and professional development. In sum, the proposed project and training plan will
support the applicant’s career goal of becoming a professor at a research university and enable her to develop
a rigorous and novel research program at the intersection of cognitive, affective, and developmental science.

Public health relevance
PROJECT NARRATIVE The goal of this project is to develop and test a framework describing the multimodal affective environment that supports language development in early childhood. Using computational analyses of infants’ at-home environments in the first years of life as well as a series of tightly-controlled experiments, we ask (1) how affective contexts shape word learning and (2) how children with depressed caregivers adapt their learning strategies to the decreased affective information in their environments. Understanding how children with depressed caregivers use affective information to learn new words may inform tailored efforts to promote equity in educational outcomes.